High-throughput Discovery of Antibodies against Understudied Membrane Proteins using mRNA

ABSTRACT
Of the 20,000 genes in the human genome, approximately 4,000 are considered “druggable”. However, less
than 10% of these druggable proteins are actually targeted by FDA-approved drugs. In 2014, the Illuminating
the Druggable Genome (IDG) project was launched by the NIH to address the large number of druggable
targets with high therapeutic value that are understudied. The IDG has selected 178 G protein-coupled
receptors (GPCRs) and ion channels as a focus of their program, as these families make up the largest
families of the druggable genome and have high potential to impact human health. Due to their difficult biology,
many of them are completely unexplored. To enable this research, the IDG has called for the development of
reagents such as monoclonal antibodies (MAbs) against these 178 GPCRs and ion channels, most of which
currently have no commercially available high quality MAbs. MAbs that target membrane proteins such as
GPCRs and ion channels can be exceptionally useful in research, diagnostic, and therapeutic applications.
However, for most membrane proteins, there are no MAbs available that recognize the native protein on the
cell surface. Efforts to identify MAbs against these challenging targets are limited by the difficulty of expressing
and purifying membrane proteins in exogenous systems and by conventional MAb isolation strategies that
immunize mice with purified protein. A novel approach to identify membrane protein MAbs in a high-throughput
manner is needed to derive MAbs against these difficult targets.

Public health relevance
PROJECT NARRATIVE This proposal will contribute to public health and the cure of human disease by generating high quality MAbs against understudied membrane proteins, enabling their development for biomedical research and potentially therapeutics.